Core C - Administrative Core

Summary/Abstract – Administrative Core
The long-term objectives of this Program Project are to elucidate host and viral
mechanisms that tilt the interaction of herpes simplex virus (HSV) and neurons
either towards lytic infection or towards latency. HSV latency is the most fascinating
biological property of the virus and its most important clinical feature, and
understanding HSV latency may lead to new therapies or even a cure for this
widespread pathogen. Five different components of the program project -- three
projects and two cores -- perform the research to address these objectives. These
scientific components are distinct, yet very closely interwoven, so lack of coordination
could delay progress. To coordinate and integrate these scientific components, and
monitor progress, the Program Directors lead weekly phone conferences and
multiple face-to-face meetings of the project and core leaders and more junior
personnel to share results and hypotheses, plan experiments, arrange reagent
sharing, discuss interpretations, and write papers. At least one meeting each year
coincides with a symposium. Both an internal and an external advisory committee
provide feedback. The Program Directors also oversee financial matters.
Administrative assistants support the program directors in these efforts by arranging
phone conferences, meetings, and travel, and helping with shipping of reagents,
sharing of data and manuscripts, and with financial oversight. The Administrative
Core will also establish a website hosted in the Department of Microbiology and
Immunobiology that allows data sharing among all the investigators in the Program
Project.